Component for Institution # 264313

The Administrative Core of the NIDA P30 Core Center of Excellence at Temple University provides the
organizational structure to support the activities that create centeredness including thematic integration,
interdisciplinary research, and synergy. The goals of the Administrative Core fall into five broad
categories: 1) to promote excellence in substance abuse research through integration of the activities of
the Research Support Cores and Pilot Project Core; 2) to expand substance abuse research by
engaging new investigators in the P30 Center and disseminating research findings about drugs of
abuse, addiction, pain and HIV; 3) to foster centeredness through facilitating interactions among the
Cores and organizing opportunities for scientific exchanges by Center investigators, 4) to provide
education, training and mentoring to future generations of scientists in the field of substance abuse
research; and 5) to deliver administrative support services to the Center. The Administrative Core
oversees the operation, progress and evaluation of the Research Support Cores through meetings of
the Internal Steering Committee and annual reviews by the External Advisory Board. The External
Advisory Board is composed of leading senior investigators in the field with international reputations for
research excellence in addiction, pain, and the effects of drugs of abuse on HIV pathology. The
External Advisory Board provides critical feedback about the effectiveness of the individual Cores,
progress of the overall NIDA P30 Center, and strategies to enhance Center activities. The
Administrative Core organizes scientific programs and seminars to keep investigators abreast of new
developments in the field. It facilitates dissemination of Center activities and research outcomes. The
Center Director and Co-director, through the Administrative Core, help to engage investigators nation-
wide to utilize the Research Support Cores as a way to extend and expedite NIH-funded research
projects using state-of-the-art multi-disciplinary approaches. As such, the Administrative Core provides
all of the essential functions of the NIDA P30 Center needed to operate efficiently and to achieve its
goals of enhancing substance abuse research.